A randomized controlled pilot study to examine the impact of a filmed dramatized story intervention (telenovela/soap opera) for HIV prevention in Latinas

PROJECT SUMMARY/ABSTRACT
Latinas continue to be affected disproportionally by HIV in the United States (US). Often, Latinas are not
aware of their HIV status. Also, their perception of low risk for HIV interferes with condom use, HIV testing and
lack of awareness, access, and use of Pre-exposure Prophylaxis [PrEP]. About 60% of total HIV cases in NC
occur among women of childbearing age, thus vulnerability to HIV is particularly acute among Latinas between
ages 18 and 44 years old, an age group with the highest rate of new HIV infections in NC. These disparities
indicate that HIV prevention among Latinas is urgent; therefore, we propose an innovative intervention – a
filmed dramatized story (telenovela/soap opera) Infección de Amor (Love Infection) – culturally tailored for
Latinas in the US and delivered online. Infección de Amor was filmed and developed but has not been tested
with our target audience. The proposed study will pilot test IA and move the intervention to online using a
website that will allow individual access around the clock from any location and device, such as a smartphone,
ensuring wide dissemination of the intervention in the future. We propose a two-year planning grant (R34) to
prepare for an R01 efficacy trial. Our aims are to: 1) Develop the intervention delivery website, conduct a
website usability test, and test the feasibility and acceptability of the IA intervention (four telenovela episodes)
with 10 Latinas, 2) Conduct a randomized controlled pilot study to examine change in HIV prevention
behaviors (condom use; HIV testing; and PrEP awareness, access, and use) comparing 71 intervention and 71
control Latinas from baseline (Time 1 [T1], 0 months) to post-active intervention (Time 2 [T2], 1 month), and to
six months follow-up, a period with no contact from the study staff (Time 3 [T3, 7 months]), and 3) Complete
establishing the study infrastructure, expanding our multidisciplinary team, building our research partnerships
with the community, finalize the protocol and training materials, refine recruitment and retention strategies,
data collection and data management procedures, and obtain institutional review board approval in preparation
for an R01 efficacy study. We address the National Institute on Drug Abuse (NIDA) goal #4: increase NIDA
research and programs’ public impact. We aim to use a novel intervention to advance HIV prevention for
Latinas. We will implement a culturally durable and feasible intervention for Latinas.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) This proposed R34 clinical trial planning grant will assess the feasibility and acceptability, and change in HIV prevention behaviors from a filmed dramatized story intervention (telenovela/soap opera) called Infección de Amor (Love Infection), that is culturally tailored and technology delivered for Latinas; a group of women that is disproportionally affected by HIV in the United States. This study will develop innovative approaches to advance health and wellness for Latinas by reducing the risk of acquiring HIV. This intervention has not been tested with our target audience, and there is no evidence of other telenovela interventions for HIV prevention in Latinas tested previously; if the findings support the feasibility and acceptability of the intervention, the next step will be to test the intervention in a randomized clinical trial.